INFORMED CONSENT TO DNA BANKING FOR RESEARCH

DESCRIPTION: The applicants will continue work on a consent form for a DNA bank at the University of Pennsylvania. Patients in the GCRC for other studies are invited to donate to the DNA bank; the investigators will use that population as test subjects for an improved consent process. They will use focus groups and then a "think aloud" protocol (a modified focus group) and prospective jurors as test populations. They will then randomize 2500 subjects, half of whom will use a consent process using vignettes, to see if that technique elicits more informed consent. Subjects will complete a questionnaire about the consent process, assessing their understanding of key issues.